Core B: Organoid Biobank

CORE B – ORGANOID BIOBANK
PROJECT SUMMARY
Organoids are microscopic self-organizing, three-dimensional cellular structures that are grown from stem and
progenitor cells in vitro. These culture models recapitulate many structural and functional aspects of their in vivo
counterpart organs. This versatile technology has led to the development of many novel human cancer models,
which have been widely validated as having superior capabilities to conventional 2D cancer cell lines in
recapitulating human carcinoma biology. Over the last several years, several investigators at CSHL, including
members of the Program, have come together to establish a unique Organoid Biobank. Through a productive
collaboration with clinical oncologists, surgeons, and pathologists at several health centers, we have obtained
hundreds of fresh tumor specimens, which have been adapted as primary cultures as organoids. Rigorous
standard operating procedures annotated the genome and transcriptome of these cultures, resulting in the
classification of each tumor organoid into molecular subtypes. Importantly, this biobank includes numerous
basal-subtype models of pancreatic and breast carcinoma, which are a major focus of this Program. During the
next funding cycle, Core B will support all three Projects in the use of organoid models of cancer, which will
include a) establishing novel organoid models of basal-subtype breast and pancreatic cancer b) performing
genomic and transcriptomic characterization of these models c) assisting investigators in propagating organoid
cultures for various perturbation experiments d) assisting investigators in performing customized assays for
characterizing organoid morphology, migration, and lineage identity. Collectively, these valuable resources and
services will enable a deep investigation of transcriptional and splicing dependencies in cancer and allow for the
identification of biomarkers to predict therapeutic efficacy.

Public health relevance
CORE B – ORGANOID BIOBANK PROJECT NARRATIVE Tractable experimental models that accurately recapitulate human pancreatic and breast carcinoma biology are critical to the overall goal of this Program Project Grant. Core B will provide all three Projects with access to a large human patient-derived organoid biobank, which includes hundreds of breast and pancreatic cancer samples. Expertise and methods for evaluating transcriptional and splicing dependencies will be provided to provide deep insights into biomarkers and molecular mechanisms.